JAK Specific Signaling in PTOA-associated Joint Degeneration and Pain

PROJECT SUMMARY
Osteoarthritis (OA) is a total joint disease characterized by articular cartilage degradation, synovial
inflammation, meniscus degeneration, subchondral bone sclerosis, osteophyte formation, and joint pain. It afflicts
nearly 1/4 of the US population resulting in healthcare expenditures exceeding $185 billion annually. Despite the
severity and impact of OA on individuals and our health care system, only recently have there been advances in
understanding the molecular, cellular and tissue events underlying OA development and progression. It is well
established that inappropriate expression and activation of catabolic enzymes underlies the joint cartilage
destruction observed in OA, however the precise molecular mechanisms responsible for promoting joint cartilage
catabolism is not well understood, nor is there a defined understanding of the molecular mediators of OA-
associated pain. Recently, we determined that IL-6/JAK signaling is a critical mediator of both cartilage
catabolism and pain in post-traumatic OA (PTOA) of male mice, and that particular JAK signaling molecules
likely mediate PTOA-associated cartilage catabolism and pain. Here we will explore the relevant downstream
mechanisms and test specific pharmacological inhibitors of these pathways as disease modifying osteoarthritis
drugs (DMOADs). Using cartilage-specific and nociceptive neuron-specific inducible loss-of-function genetic
approaches, we will identify the Janus Kinases (JAK1, JAK2, and/or TYK2) that mediate both/either the cartilage
specific catabolic effects and the nociceptive pain responses associated with PTOA. A variety of in vivo and ex
vivo approaches will identify the particular JAKs and critical downstream effectors as important regulators of
PTOA-associated cartilage catabolism and pain, while simultaneously testing selective JAK inhibitors as
potential translational DMOAD therapies.

Public health relevance
PROJECT NARRATIVE Various proinflammatory cytokines, many of which capable of activating the Janus kinase (JAK) signaling pathways, are elevated within joint tissues following traumatic joint injury. Using murine genetic and joint injury mouse models, we demonstrate that enhanced IL-6/JAK/STAT signaling is a critical mediator of joint cartilage catabolism and pain during post-traumatic osteoarthritis (PTOA) in male mice and that JAK inhibition reverses both IL-6 induced molecular mediators of cartilage catabolism and neuropathic pain in vitro. Since we show that joint injury specifically activates JAK1 and JAK2 in joint cartilages, and TYK2 and JAK2 in nociceptive neurons of dorsal root ganglia (DRG) associated with joint structures, we propose using mouse conditional genetics to test the precise tissue specific requirements for these JAKs in propagating PTOA-associated joint cartilage catabolism and pain, while simultaneously uncovering their critical downstream signaling mediators and testing the local delivery of selective JAK inhibitors as translational disease modifying osteoarthritis drug (DMOAD) therapies.